Bioresorbable zinc-based drug-eluting stents for pediatric cardiovascular applications

Summary
This grant application is a renewal of an NIH-funded project in developing bioresorbable metallic stents in
treatment of heart disease. The goal of this study is to optimize a novel bioresorbable zinc-based drug-eluting
stents for pediatric cardiovascular applications and conduct comprehensive in vitro and in vivo testing to evaluate
their efficacy.
Coarctation of the aorta is a common heart defect in children, causing narrowing of the aorta and resulting
in various symptoms. Traditional metallic drug-eluting stents are not suitable for pediatric patients due to their
interference with artery development. To address this, biodegradable drug-eluting stents (BDES) are being
explored. However, current materials have limitations in mechanical strength and degradation. To overcome this,
a new solution called biodegradable zinc-lithium-manganese (Zn-Li-Mn) stents with a drug-eluting coating (Z-
DES) has been developed. These stents offer mechanical strength, ductility, and stable biodegradation.
The study aims to optimize the composition and configuration of Z-DES and evaluate its efficacy. In Aim
1, different Zn-Li-Mn alloys coated with PLLA and Sirolimus will be tested for mechanical properties and
biocompatibility. Aim 2 focuses on assessing Z-DES biodegradation and safety in rat abdominal aortas. Aim 3
aims to validate Z-DES in a large animal model with narrowed aortas. The success of this research could lead
to biodegradable pediatric stents that significantly improve patient outcomes and revolutionize cardiovascular
interventions in children.

Public health relevance
Narrative This study aims to develop a new generation of Zn-based drug-eluting bioresorbable cardiovascular stents that possess sufficient mechanical strength, stability, and ideal biocompatibility without toxicity. The use of these novel stents would improve patients’ quality of life by providing a better recovery experience and eliminating the need for a second surgery and long-term complications due to their full biodegradability, particularly for young children.